Multimodal Intravital Microscope for USC Shared Resource

This proposal is submitted to purchase a new high-end multimodal multiphoton
fluorescence microscope, a Leica Stellaris 8 DIVE/FALCON system powered by
Chameleon Discovery NX laser from Coherent. The new instrument will be operated and
maintained by the Multi-Photon Microscopy Core at the Zilkha Neurogenetic Institute,
Keck School of Medicine of USC. The purpose of this new microscope is two-fold: to
replace the only currently used system that is aged and failing and to bring currently nonexistent
imaging capabilities and versatility for a large user base at USC. This multimodal
multiphoton system will provide deep imaging of intact living organs in vivo in small
animals and of tissues ex vivo with ultra-high sensitivity, high spatial and temporal
resolution that other microscopes currently existing at USC cannot achieve. This new
core microscope will tremendously help several key strategic research priorities at
KSOM/USC, including to improve our understanding of the miracle of the brain, the
normal functioning of the body's organs, the discovery of disease mechanisms and
biomarkers, testing novel pharmaceuticals and biomedical devices, and the application
of stem cells and regenerative medicine to cure degenerative disorders, and will help to
keep USC at the forefront of worldwide biomedical research. This new core microscope
is essential for continuing the work of a large research base of 23 NIH-funded
investigators who have been long-term users from seven major user groups, including
kidney, liver, stem cells, brain, vision science, cancer, and dental imaging representing
six USC schools/campuses including Medicine, Engineering, Pharmacy, Dentistry,
College and the Children's Hospital of Los Angeles. The new microscope will re-energize
USC's research activities and maintain the only available core service for deep tissue
intravital imaging, therefore the USC Core Instrumentation Award program is providing
significant cost-share ($250,000). The ZNI, which is the academic unit housing this core
is fully committed to the ongoing maintenance and operation of the new microscope. The
USC Multi-Photon Microscopy Core is an integral part of the USC Center of Excellence
in Cell & Tissue Imaging, and the new microscope purchase will meet a strategic need
expressed in the USC Plan for Science and Technology Facilities by providing
instrumentation and collaborative expertise for biomedical research aimed at improving
human health.
Project Summary/Abstract

Public health relevance
This new shared instrument, a Leica Stellaris 8 DIVE/FALCON multimodal multiphoton fluorescence microscope will be a unique system at USC dedicated to providing ultra-sensitive, deep tissue imaging of intact living organs in vivo in small animals with high spatial and temporal resolution. The new core microscope is essential to a large research base of 23 NIH-funded investigators from seven USC schools/campuses. The new microscope will allow these users to perform quantitative imaging of organ structure/function over time during disease processes to better understand the pathomechanisms of chronic kidney disease, hypertension, liver injury and fibrosis, alcoholic liver disease, cancer, aging, blindness and neurodegeneration (Alzheimer's disease), stress, stem cell function and tissue regeneration. Project Narrative